Selective Galactosylceramidase Ablation to Study the Pathogenesis of Krabbe Leukodystrophy

Krabbe leukodystrophy (KD) is a fatal neurodegenerative lysosomal storage disorder caused by deficiency of
galactosylceramidase (GALC) that affects both central and peripheral nervous systems. KD manifests in infants
in the first few months of life and presents with severe irritability, muscle rigidity and motor deterioration, which
quickly progresses to overall clinical decline and death within months. Unfortunately, there is no cure for KD. Our
limited understanding of the pathogenesis is based on clinical data and on the spontaneous twitcher mouse
model. Hematopoietic stem cell transplantation (HSCT) partially attenuates the course of KD only if performed
before the onset of symptoms, presumably because stem cell derivatives secrete GALC that is uptaken by
myelinating glia via the mannose-6-phosphate receptor, so called cross-correction. However, it is not clear how
efficiently cross-correction happens in vivo, if only myelin-forming glia need to be corrected and at which
developmental stage. Furthermore, accumulation of the lipid psychosine due to GALC deficiency contributes to
KD by killing myelin-forming glia and neurons, but the relative importance of psychosine, its origin and the
sequence of pathogenic events is unclear. We recently developed a conditional Galc floxed mouse and found
that: 1) A KD-like phenotype similar to twitcher is obtained when Galc ablation is induced ubiquitously [Galc-iKO]
at P4 or before. In contrast, induction at P6 or later significantly delayed the phenotype and prolonged survival
(~25 days). Galc deletion before P4 caused severe developmental brainstem problems that were milder if
deletion was induced after P6, indicating that GALC may be required for brainstem development; 2)
Oligodendrocyte (OL)-specific Galc conditional knockout [Galc-CKO] results in a phenotype that includes tremor,
wasting, kyphosis, motor defects, demyelination and mild axonal degeneration, but that is not as severe as Galc-
iKO mice, suggesting that Galc deficiency in OLs may be not sufficient to trigger a complete KD phenotype; and
3) GALC uptake is less efficient in Galc-null cells in vitro, and surrounding WT cells provides minimal GALC to
Galc-deficient OLs in vivo, indicating inefficient cross-correction of GALC. We propose 3 Aims to determine; 1)
if GALC has an early role in brain development and contributes to mortality, 2) the key cells in the progression
of KD pathology, and 3) the efficiency of cell-specific cross-correction of GALC. By combining a series of in vitro
experiments with the comparison of cell-specific, time–specific and constitutive deletion of Galc in vivo, we will
test the following 3 hypotheses that derived from our preliminary data and from the clinical experience: 1) GALC
has specific developmental roles during critical periods including P4-6 in Krabbe mice; 2) any brain cell can
produce psychosine or be the target of toxicity; 3) HSCT fails to cure KD due to inefficient cross-correction of
GALC. Our results will help to understand the disease mechanisms of KD and the limitations of HSCT, which
will allow the development of better therapies for KD and similar lysosomal, neurodegenerative and
demyelinating diseases.

Public health relevance
Krabbe leukodystrophy (KD) is a progressive and fatal neurologic lysosomal storage disorder that usually affects babies and causes death before two to three years of age. Hematopoietic Stem Cell Therapy is not sufficient to improve the long-term survival of most patients with KD and the outcome of patients, with or without therapy, remains dismal. Using our newly developed KD animal model, we will discover the critical time that the disease starts and identify which cell type needs to be targeted with therapy.